Regulation of L-type calcium channels by CaBP4

Project summary/Abstract The long-term goal of this research is to understand the mechanisms controlling Ca2+ signaling at the photoreceptor synapse and their significance for vision. We have identified a family of calmodulin-like Ca2+-binding proteins (CaBPs), one of which (CaBP4) is specifically localized at the synaptic terminals of photoreceptors in the retina and inner hair cells in the ear. CaBP4 associates with and modulates Cav1 (Cav1.4 and Cav1.3) voltage-gated Ca2+ channels that mediate Ca2+-dependent glutamate release at ribbon synapses. CaBP4 undergoes light-dependent phosphorylation which regulates its functional interaction with Cav1 channels. Mice lacking CaBP4 (Cabp4-/-) show a loss of photoreceptor synapses, impaired photoreceptor transmission, and a visual deficit similar to that seen in mice lacking Cav1.4. In addition, human mutations in the genes encoding CaBP4 and Cav1.4 have been linked to incomplete congenital stationary night blindness (CSNB2), which involves visual defects that are consistent with abnormal photoreceptor transmission. We hypothesize that CaBP4 is an integral subunit of photoreceptor Cav1 channels, and that disruption of this interaction causes abnormalities in photoreceptor synapses and visual impairment. The molecular characterization of Cav1/CaBP4 interaction is therefore crucial for understanding Ca2+ signaling in normal vision and in the physiopathology underlying CSNB2. To this end, we will use a multidisciplinary approach to 1) map the subcellular distribution of Cav1 channels and CaBP4 in mouse retina, 2) define the molecular determinants underlying CaBP4/Cav1 interactions and the impact of CSNB2 mutations, 3) elucidate the role of CaBP4/Cav1 interactions in maintaining photoreceptor synapses. These studies will fill a major void in our understanding of factors controlling photoreceptor Cav1 channels and how dysregulation of these channels may lead to CSNB2 and potentially other visual disorders.

Public health relevance
Project narrative. This study will provide molecular insights into the factors controlling Ca2+ signals at the photoreceptor synapse and their importance for the proper development and function of the synapse. This research will may reveal how dysregulation of Ca2+ signals leads to CSNB2 and pave the way for the development of new therapies for CSNB2 and other visual disorders. __SpecificAimsTextDelimiter__ SPECIFIC AIMS Cav1 voltage-gated Ca2+ channels mediate L-type Ca2+ currents that trigger tonic release of glutamate from photoreceptor nerve terminals in the dark. This process ensures accurate transmission of visual information in the retina. Human mutations in the major photoreceptor Cav1 channel, Cav1.4, cause incomplete congenital stationary night blindness 2 (CSNB2), which is characterized by impaired rod photoreceptor transmission and low visual acuity in darkness. Therefore, factors that regulate Cav1 channels can profoundly impact this first step in the visual pathway. Of the multiple classes of Cav1 channels, Cav1.4 and Cav1.3 are enriched in synaptic terminals of rods and cones, respectively. However, the properties of heterologously expressed Cav1.3 and Cav1.4 channels do not completely match the behavior of the photoreceptor Ca2+ channel. Relevant in this regard are CaBPs, a family of Ca2+-binding proteins that are similar to calmodulin (CaM). We have shown that CaBP4, which is expressed mainly in photoreceptor synaptic terminals, binds to the pore-forming a1- subunits of Cav1.4 and Cav1.3. This interaction enhances current flow through these channels in transfected cells in a way that is consistent with their native properties in photoreceptors. CaBP4 undergoes light- dependent phosphorylation which may regulate its functional interaction with Cav1 channels. Targeted disruption of the gene encoding CaBP4 in mice (Cabp4-/-) causes defects in photoreceptor synaptic function and organization similar to those in mice that lack photoreceptor Ca2+ channels. Moreover, electroretinograms from Cabp4-/- mice show a reduced b-wave, similar to patients with CSNB2. Finally, human mutations in CaBP4 also have been linked to CSNB2. Based on these findings, we hypothesize that CaBP4 is an integral subunit of photoreceptor Cav1 channels, and that disruption of this interaction causes abnormalities in photoreceptor synapses and visual impairment. The goal of this proposal is to characterize the mechanisms and functional impact of CaBP4 as a Cav1 modulator in photoreceptors. This research may reveal how dysregulation of presynaptic Ca2+ signals in photoreceptors leads to CSNB2 and pave the way for the development of new therapies for CSNB2 and other visual disorders. Our specific aims are: Aim 1. To study the interaction and map the subcellular distribution of CaBP4 and Cav1 channels in the retina. A prediction of our hypothesis is that CaBP4 should physically associate and colocalize with Cav1 channels at the photoreceptor synapse. To test this, we will use biochemical assays to identify presynaptic CaBP4/Cav1 complexes in photoreceptors. High-resolution immunocytochemical analyses will indicate where, within the photoreceptor synapse, these complexes are localized. Aim 2. To define the molecular determinants underlying CaBP4/ Cav1 interactions and the impact of CSNB2 mutations. A second prediction of our hypothesis is that disrupting the binding of CaBP4 and Cav1 should prevent channel modulation. We will test this with biochemical methods to pinpoint sites in the channel and CaBP4 required for the interaction. Electrophysiological recordings will show if alterations in these sites affects Cav1 modulation by CaBP4. With these methods, we will also determine how CSNB2 mutations in CaBP4 and Cav1.4 affect their interaction. Aim 3. To characterize CaBP4 phosphorylation as a mechanism for Cav1 regulation in the retina. Phosphorylation of CaBP4 at serine37 is necessary for its ability to enhance Cav1 channel opening. Therefore, preventing CaBP4 phosphorylation should cause loss-of-function defects in Cav1 channels and photoreceptor synapses, similar to Cabp4-/- mice. We will test this first by characterizing the molecular mechanism underlying CaBP4 phosphorylation. We will then evaluate the consequences of preventing CaBP4 phosphorylation using pharmacological and transgenic strategies. Aim 4. To characterize the significance of CaBP4 and Cav1 during photoreceptor synapse development .The retina from Cabp4-/-- mice shows decreased number and aberrant morphology of photoreceptor synapses, which is strikingly similar to that in mice lacking Cav1.4 channels. If these defects are related to loss-of-function of Cav1 channels, they should show a similar developmental onset in Cabp4-/- mice and mice lacking Cav1.4 channels. Moreover, they should be rescued by manipulations that increase Cav1 Ca2+ signaling. We will test these predictions with morpholological/immunocytochemical studies.